Core A: Human Metabolism

Biomedical Core A (Human Metabolism): Summary
The UCSF-NORC has facilitated clinical and translational studies in humans. During the first award period,
members of the UCSF-NORC had greater access to clinical research facilities and services that are housed in
different research units and departments, and the NORC administrative infrastructure was able to efficiently
coordinate their activities to serve NORC research needs. The NORC Human Metabolism Core will continue to
provide that coordinating function to integrate Core activities with NORC research, and will facilitate greater
access to a metabolic laboratory assay unit in this new grant period. The current and newly proposed NORC
Human Metabolism Core services include:
1) Body composition, exercise, and metabolism testing to measure metabolic output and functional
performance, as well as total and regional fat content, lean body mass and bone density.
2) One of the world's most advanced radiologic imaging facilities that will visualize and quantitatively
measure anatomical structures and their intra-tissue lipid and water content.
3) Consultation services to provide assistance with nutrition and biobehavioral measurements, research
study design, participant recruitment, biostatistical analysis, data management, and grant/manuscript editing.
4) Clinical research services to assist with participant measurements, metabolic procedures, phlebotomy,
and biospecimen processing and shipments.
5) In the current application, we propose to expand our Core services to include a new metabolic
laboratory assay service which will run hormone, adipokine and inflammatory panel assays for NORC-related
studies.
Currently, 23 of the total 58 UCSF-NORC investigators use or plan to use the Human Metabolism Core
services to conduct obesity-related studies and measure metabolism, physical activity, nutrition, body fat
content and distribution, and a range of obesity related laboratory biomarkers With the breadth of research
programs at UCSF, continued NORC support for a dedicated NORC Human Metabolism Core will enable
exciting research programs to pursue novel, previously unexplored directions in obesity, nutrition and/or
metabolism research.